Poverty-Related Risk Factors for Auditory and Language Deficits in Children

Project Summary/Abstract
Ever since Lyndon Johnson declared a War on Poverty in the 1960s, developmental scientists have been
assessing the effects of poverty on child development, especially language acquisition. Ample evidence shows
that some of the negative effect can be explained by social determinants: how parents talk to their children,
parental stress, and parents’ knowledge of child development. But these factors fail to account for all, or even
most of the language deficit seen in children of poverty. The goal of this project is to explore the hypothesis that
poverty-driven biological determinants can explain previously unaccounted for variance in those deficits.
Two novel mechanisms are proposed to account for additional variance in the language deficits of children of
poverty: (1) Mothers and children in poverty face healthcare inequities that put these children at enhanced risk
of delays in the development of auditory functions, beyond raised thresholds; (2) Deficits in suprathreshold
auditory functions negatively impact language acquisition for children in poverty more than for children from
middle-class backgrounds because optimal social factors buffer effects for the latter group. With these
possibilities in mind, the overall goal of this current project is to explore the comprehensive hypothesis that being
born into poverty imposes myriad risk factors for delayed development of language skills, arising from both social
and biological determinants. The social determinants to be studied include: (1) impoverished parental language
input; (2) enhanced parental stress; and (3) poorer parental knowledge of child development. The biological
determinants include: (1) premature birth and (2) chronic otitis media with effusion (OME). The most innovative
aspect of this work is that it will explore the hypothesis that prematurity and OME are responsible for delays in
development of suprathreshold auditory processes critical to language acquisition. Children born into poverty
are both more likely to experience these health problems and less likely to benefit from the mitigating effects of
a highly supportive environment. This project seeks: (1) to measure the contributions of each of these sources
of deficit by examining auditory (spectral and temporal processing) and language (lexical, morphosyntactic, and
phonological) functioning in young children born with varying SES; (2) to expand our understanding of the
connections from perinatal/postnatal health conditions to development of auditory functions to language learning;
and (3) disentangle the effects of poverty and systemic racism on these barriers to language acquisition. These
goals will be addressed with three Specific Aims. Aim #1 will quantify the direct effects of the social and biological
determinants described above on language skills. Aims #2 and #3 will focus on the proposed biological
determinants, assessing the effects of premature birth and OME on the emergence of spectral and temporal
processing (Aim #2) and assessing the contributions of spectral and temporal processing to language acquisition
across the socioeconomic continuum (Aim #3). Results will enhance our understanding of the root sources of
language deficit for children in poverty, as well as for all children born too soon or experiencing OME.

Public health relevance
Narrative As a society, we have long recognized the significant risk for language delays facing children born into poverty. Research efforts to understand this risk have appropriately focused on social determinants such as parental interaction styles, parental stress, and parental knowledge of child development, but those factors have never been able to fully account for the problem. This project expands our search for explanatory factors by proposing that poverty-related healthcare inequities put children at risk for premature birth and more-frequent otitis media with effusion, and these biological factors, in turn, delay development of essential auditory skills needed to acquire language on a typical timetable.